Research Training in Otolaryngology

DESCRIPTION (provided by applicant): We propose to continue our program of research training for medical students and residents in the basic sciences related to Otolaryngology-Head and Neck Surgery at the University of North Carolina at Chapel Hill. The training faculty includes twelve members of the Department of Otolaryngology-Head and Neck Surgery at the University of North Carolina at Chapel Hill as well as selected faculty from other departments whose research intersects with Otolaryngology/Head and Neck Surgery. Seven of these faculty study auditory neurobiology or perception. Other training faculty work on cancer mechanisms and epidemiology, sinus and airway function. An Internal Advisory Committee consisting of the Department Chair, and two external faculty members in complementary areas provides oversight of the training program and trainee selection. An External Advisory Committee consisting of three senior scientists in the research training areas provides guidance regarding the overall program. The training program consists of two tracks. The first track is for medical students interested in Otolaryngology-Head and Neck Surgery and offers either a short-term (summer) or a 1-year research opportunity in any of the laboratories in the Department. The second track is for residents in the Otolaryngology program. One resident in each incoming class will receive 2 contiguous years of research training in the Department's research laboratories, in preparation for careers as academic Otolaryngologists and researchers. All levels of the training program are designed to provide cross-fertilization between trainees in Otolaryngology and basic scientists. Didactic elements of the training, including coursework, training in research ethics, and grantsmanship, are designed to ensure the production of outstanding researchers. The long-term goal is to produce academic clinicians in the field of Otolaryngology-Head and Neck Surgery with exceptional research credentials.

Public health relevance
PUBLIC HEALTH RELEVANCE: Research Training in Otolaryngology is a formal research training program at the University of North Carolina at Chapel Hill for medical students and Otolaryngology/Head and Neck Surgery (ear, nose and throat) residents. Training areas include the hearing sciences and neuroscience, head and neck cancer research, and sinus and airway function. The program seeks to train outstanding academic clinician- scientists who can carry out bench-to-bedside research related to Otolaryngology.